Molecular mechanisms of spectrin-dependent axonal organization and function in cerebellar granule cells

PROJECT SUMMARY
βII-spectrin (encoded by SPTBN1), is a ubiquitous component of the submembrane neuronal cytoskeleton. βII-
spectrin binds F-actin and ankyrins to organize complex networks of ion channels, membrane transporters and
cell adhesion molecules. βII-spectrin also promotes bidirectional transport of organelles and vesicles. Our lab
recently reported de novo SPTBN1 variants as the genetic cause of a developmental delay syndrome that is
comorbid with intellectual disability, autism spectrum disorder, ADHD, and seizures. However, the neuron types
and brain circuits most vulnerable to deficits in βII-spectrin function and their specific contribution to the diverse
neurological presentations are not fully elucidated. My preliminary studies indicate that βII-spectrin plays
important roles in modulating cerebellar function and that cerebellar dysfunction may contribute to the SPTBN1
syndrome. To begin to unravel the roles of βII-spectrin in the cerebellum, I will focus on investigating its function
in cerebellar granule cells by determining how βII-spectrin promotes: 1) the organization of excitable axonal
domains and 2) axonal organelle dynamics.

Public health relevance
PROJECT NARRATIVE SPTBN1 variants cause a global developmental delay syndrome of complex presentation. However, the neuron types that are most vulnerable to deficits in βII-spectrin (encoded by SPTBN1) are unknown. We will determine how βII-spectrin contributes to the organization of excitable axonal domains in cerebellar granule cells.